Patient-Centered Outcomes in Carotid Artery Stenosis

Project Summary Abstract
Older patients with carotid artery atherosclerotic disease are at risk of stroke, and some evidence suggests
that people are affected by their carotid artery stenosis even in the absence of a stroke. These non-stroke
outcomes are poorly studied, but may include cognitive decline, sleep disturbances, and mood abnormalities.
Whether medication or surgery for carotid artery stenosis improves these non-stroke symptoms is unclear.
Therefore, it is necessary to identify the best way to measure these non-stroke patient-reported outcomes to
be able to study how carotid artery stenosis treatment affects these symptoms. A reliable and accurate
measurement of patient-reported outcomes in carotid artery stenosis will enable identification and tracking of
these symptoms throughout the treatment continuum.
Research Aim 1 of this project will use instruments developed by the National Institutes of Health to measure
quality-of-life and function across diseases, as well as a robust, multidimensional assessment of cognition (NIH
Patient-Reported Outcomes Measurement Information System; NIH Toolbox-Cognitive Battery). These will be
collected on people with a diagnosis of carotid artery stenosis, including those with prior medical or surgical
treatment, and newly diagnosed carotid artery disease requiring surgery. Patients will have at least two
timepoints 6 months apart, with more frequent assessments directly after surgery in patients undergoing
surgery during this study period.
Research Aim 2 of this project will use interviews and focus groups to gain patient and caregiver perspectives
about non-stroke changes that may have occurred after revascularization for carotid artery stenosis. This data
will help select the best measures of non-stroke outcomes for carotid artery stenosis to be used in large scale
trials evaluating which treatment is best for which patients.
For older patients with carotid artery disease, this research will ensure better alignment of treatment with the
4M Geriatric Framework of Age-Friendly Health Systems. With this lens, we will better understand how to align
treatment of carotid artery stenosis with 1) what matters most to patients, 2) how medication treatment effects
older patients, 3) how treatment can improve mentation, and 4) how to promote mobility and independence in
this complex patient population.

Public health relevance
Project Narrative/ Relevance to Public Health Blockage of the carotid arteries by plaque can cause stroke, particularly in people over 65 years old, and surgery is often done to decrease the chance of stroke when carotid narrowing is found. The goal of this study is to see what activities are most important for older people with carotid artery disease, and how medicine or surgery can help them perform these activities. In this study, we will ask questions about how well older patients with carotid narrowing think, feel, and are able to do what makes them happy before and after surgery to see if surgery improves these things, even though surgery is performed to reduce their risk of stroke.